Characterizing HIV-1 Env conformations susceptible to attack by non-neutralizing antibodies

SUMMARY
While current antiretroviral therapies (ART) are able to control HIV replication, they are unable to fully restore
health or a normal immune status. ART-treated individuals still experience several co-morbidities including
increased cardiovascular disease, bone disorders, and cognitive impairment. Most importantly, therapy
interruption leads to the re-emergence of viral replication and progression to AIDS. Therefore, new approaches
aimed at eradicating or functionally curing HIV infection are desperately needed. An under-studied strategy to
eliminate latently infected cells after viral reactivation relies on the ability of immune cells to mediate antibody-
dependent cellular cytotoxicity (ADCC). The RV144 HIV-1 vaccine trial in Thailand elicited a 31.2% protective
efficacy, making it the first vaccine trial with any level of success in generating a protective response. Subsequent
analyses indicated that this modest protection was correlated with the generation of antibodies (Abs) with high
ADCC activity, in the presence of low plasma IgA Env-specific Abs. This suggests that ADCC may have
contributed to the protection observed in the RV144 trial. But key unanswered questions exist that prevent
researchers from specifically triggering the ADCC response with novel treatments or immunogens: Why did the
RV144 trial generate such a strong ADCC response? What about the CRF01_AE subtype of HIV-1, which
predominates the Thai AIDS epidemic, might make it especially susceptible to ADCC? Does Env conformation
affect ADCC responses? Answering these questions will prove crucial to the design of improved strategies to
eliminate HIV-1-infected cells. The long-term goal of the research described in this proposal is to inform the
development of new strategies for utilizing the ADCC response to eradicate the HIV-1 infection. To achieve this
goal, we will begin by describing in molecular detail the Env conformations that are susceptible to attack by Abs
that induce ADCC, and to determine the structural elements of Env from distinct HIV-1 strains that mediate
transition to these conformations. Our central hypothesis is that Env has intrinsic access to downstream
conformations that are recognized by easily-elicited non-neutralizing Abs. Some of which, like the anti-cluster A
Abs, have potent ADCC activity. In support of this hypothesis, we recently demonstrated using Ab-binding
assays, cryo-electron microscopy (Cryo-EM), and single-molecule Förster resonance energy transfer (smFRET)
imaging that HIV-1 Env can adopt a conformation that is sensitive to attack by Abs that have potent ADCC
activity (State 2A). The rationale underlying this proposal is that characterization of the structure of Env State
2A, as wells as other conformations recognized by non-neutralizing Abs, and the elements that mediate
stabilization of these conformations will inform new strategies to eliminate the latent HIV reservoir.

Public health relevance
NARRATIVE Antiretroviral therapies are able to control HIV replication, but they are unable to fully restore health or a normal immune status owing to the persistence of latently infected cells. This application proposes to use a highly multi- disciplinary approach, including antibody-binding assays, structural investigations, and single-molecule fluorescence imaging to elucidate the interaction between HIV-1 Env and easily-elicited non-neutralizing antibodies that induce antibody-dependent cellular cytotoxicity. This research will enable exploitation of this under-utilized strategy to develop new means of eliminating the latent HIV reservoir.